SouthON Conference Grant

Project Summary/Abstract
The occupational fatality rates in the Southeast region of the United States are 44% higher than
the US fatality rate. In 2019, the overall occupational fatality rate for states in our region was 6.3
deaths/100,000 workers compared to 4.4/100,000 for the US overall, and higher in all individual
states (Bureau of Labor Statistics) except Virginia. The goal of the Southeastern States
Occupational Health Network (SouthON) collaborative working meetings over the next three
years will be to continue to build upon the foundation we have established for regional
occupational health surveillance (OHS) capacity and research in the 12-state Southeastern US
region (Alabama, Arkansas, Florida, Georgia, Kentucky, Louisiana, Mississippi, North
Carolina, South Carolina, Tennessee, Virginia, and West Virginia). We will do this through:
1) continued strong regional partnerships and collaborations among state health departments,
academic partners, internal National Institute for Occupational Safety and Health (NIOSH)
researchers and surveillance experts, NIOSH-funded agricultural research centers and
education research centers (ERCs), other governmental agencies, professional organizations,
and occupational health and safety stakeholders; 2) data-driven development of occupational
injury and illness research hypotheses; 3) southeastern occupational injury and illness
surveillance and prevention activities; 4) state and southeast regional OHS capacity building;
and 5) translation of occupational injury and illness research into public health practice. The
objectives of our annual SouthON meetings are to: 1) develop common priorities for OHS
epidemiological analyses, and worksite interventions; 2) build collaborations with other
occupational epidemiologists, NIOSH, academic colleagues, Occupational Safety and Health
Administration (OSHA), worker organizations, and other OHS partners; 3) provide epidemiology
and program planning tools for OHS capacity building; and 4) promote scientific collaboration
among OHS partners in the Southeast region. NIOSH funds will support the SouthON meeting
participants.

Public health relevance
Project Narrative This proposed project is relevant to public health by: 1) identifying industries, occupations, and worker populations at high risk for work injuries and illnesses in the southeast region of the United States; 2) assessing risk factors, trends, and emerging occupational safety and health issues; 3) improving and enhancing timely occupational injury and illness surveillance systems in the southeast region; and 4) working with regional industrial, academic, governmental, and organizational partners to intervene to reduce workplace illnesses and injuries.